MACHINE LEARNING APPROACHES FOR ELECTROPHYSIOLOGICAL CELL CLASSIFICATION

ABSTRACT We will use our expertise in somatosensory organization and plasticity to develop novel and automated solutions for cell identification based upon neural activity, in order to decode the algorithms neural circuits use for information processing. Extracellular recordings in sensory cortex have been thought to primarily represent excitatory neuron activity, since these cells comprise ~80% of the total cell population. However, targeted cell recordings in S1 reveal that firing activity is dominated by inhibitory neurons, and that excitatory neurons can show 10-100 fold lower firing rates depending on cortical layer. Furthermore, new findings that reveal the complex relationship between different subtypes of inhibitory neurons make it difficult to relate blindly-recorded firing activity to local- or network-level computations. Clearly, cell-types matter, and massively parallel extracellular recordings that do not enable the simultaneous identification of multiple cell types will be limited in identifying principles for information transmission and encoding. Based on our preliminary findings, we hypothesize that the complex spontaneous and evoked spike trains from molecularly-identified neurons will provide unique and cell-type specific signatures that will enable cell identification from in vivo extracellular recordings. In collaboration with computer scientists at Carnegie Mellon, we will develop machine-learning algorithms for cell classification, using data collected from in vitro and in vivo recordings.

Public health relevance
NARRATIVE Discovery of the Rosetta stone was an archaeological breakthrough, enabling translation of Egyptian hieroglyphics from parallel texts in ancient Greek. Understanding how the activity of different neuronal subtypes contributes to information processing in the brain is in desperate need of a similar cipher. Detailed studies in the cerebral cortex have revealed principles of how small groups of neurons work together, but these small-scale interactions have been difficult to relate to computations performed by larger groups of neurons, typically recorded without knowledge of cell identity, during animal perception and behavior. We will use advances in molecular-cell identification techniques and machine learning to create an automated classifier to decipher cell identity from dense electrophysiological recordings and decode brain function from neural activity.